South Dakota Pediatric Clinical Trials Network (SoDakPCTN)

SoDakPCTN Project Summary / Abstract
The purpose of the South Dakota Pediatric Clinical Trials Network (SoDakPCTN) is to
leverage the enthusiasm and growth in pediatric research over the last decade to build capacity
and skills in clinical trials. This momentum was developed through active collaborations over the
past two decades in community-based research with tribal nations, health clinics and hospitals
to help improve the health of children in South Dakota. While South Dakota has been a regional
leader in large scale longitudinal multi-site observational studies (e.g., Safe Passage Study,
ECHO pediatric cohort), opportunities to participate in pediatric clinical research have been
limited. SoDakPCTN will be housed within the Avera Health system, a large health system
comprised of 300 locations in 100 communities throughout South Dakota and areas of the four
surrounding states. The Avera Health system includes 35 hospitals and 34 community and
critical access hospitals. The Avera health system and partners are ideally suited to conduct
high quality pediatric clinical trials that specifically reach rural, frontier, and American Indian (AI)
populations across South Dakota. The Center for Pediatric and Community Research (CPCR)
at Avera has worked to establish a robust pediatric research infrastructure that allows for large -
scale longitudinal studies that already occur within clinics, hospitals and communities across the
state, with offices in Sioux Falls, Rapid City and Pine Ridge.
SoDakPCTN will be built around three specific aims. First, build upon existing pediatric
research infrastructure to create a collaborative environment that supports state -of-the-art
pediatric clinical trials in inpatient, outpatient, and community-based settings. Second, support
career development for junior investigators and research staff in conducting pediatric clinical
trials through mentorship, professional development opportunities, and introduction to potential
hospital, clinic, and community partners. Third, using a community engaged approach, develop
research dissemination strategies and translate research findings to clinical and community
stakeholders to improve knowledge and practice.

Public health relevance
SoDakPCTN Project Narrative: Impact: Given the level of health disparities in our region, particularly amongst the AI populations, coupled with the remote nature of our rural communities, a mechanism for development of pediatric clinical trials research will not only grow pediatric research, it will improve health of children in South Dakota.